Peripheral immunity and the aging brain: Studying the relationship of platelet and neutrophil activity with markers of vascular contributions to cognitive decline and dementia

Abstract
The underlying biological causes of Alzheimer’s disease (AD) and AD-related dementias (AD/ADRD)
remain unclear. Although a vascular component in AD has been discussed since the 1960s, its
importance has increased with advancements in biomarkers and imaging techniques, and the current
interest in disease heterogeneity. A significant limitation in defining the vascular component of AD is the
frequent coexistence of cerebrovascular disease. Recent studies indicate that vascular dysfunction and
neuroinflammation may synergistically contribute to AD progression, yet the precise mechanisms
remain unclear. Our preliminary data indicate that circulating markers of vascular and immune
dysfunction, such as platelet aggregation and neutrophil levels, are associated with dementia risk and
increased AD biomarkers in cognitively unimpaired people and in people with high risk of cardiovascular
disease events. To further understand this relationship, multidisciplinary studies integrating biofluid data
with advanced imaging techniques are needed. This proposal will examine the association between
markers of vascular and immune dysfunction (platelet, neutrophil activity, and proteomic data) with MRI
measures of cerebrovascular burden in two cohorts: the Framingham Heart Study, and the ARISE-DP
cohort, which includes a diverse population with a high prevalence of cardiovascular risk factors (Aim
1); Study the relationship between these markers and PET measures of amyloid and tau pathology,
exploring potential interactions between cerebrovascular burden and amyloid positivity (Aim 2); and to
determine whether baseline vascular and inflammatory markers associate with cognitive decline and
AD biomarker progression (p-tau181 and 217). By integrating biofluid biomarkers with imaging data,
this study aims to identify novel biological mediators and therapeutic targets in AD/ADRD, ultimately
increasing our understanding of how vascular and immune dysfunction contribute to disease
progression

Public health relevance
Project Narrative This research aims to elucidate the role of vascular and immune dysfunction in Alzheimer's disease (AD) and related dementias (AD/ADRD). By examining the associations between platelet, neutrophil activity, and proteomic data with advanced imaging measures of cerebrovascular disease and AD pathology in two human cohorts, this study seeks to identify novel biological mediators and therapeutic targets. The findings from this multidisciplinary approach have the potential to improve our understanding of the disease and the identification of novel mediators and targets for intervention, ultimately benefiting individuals at risk of AD.